Restoration of mutant CFTR stability and function

DESCRIPTION (provided by applicant): Cystic Fibrosis (CF) is principally caused by deletion of Phe 508 in the cystic fibrosis transmembrane conductance regulator (CFTR) protein (ΔF508), a residue that is critical for both intra-domain and inter-domain contacts controlling thermodynamic stability and channel activity. We now appreciate that folding in the cell is not only about the primary sequence; rather it is managed by an extensive protein homeostasis or 'proteostasis' biology that generates, maintains and destroys the protein fold when it is damaged or no longer required (Science (2008), 319: 916; Science (2010) 329, 766). Because the ΔF508 structure is unstable, it is degraded, leading to loss-of-function disease. The Riordan and Balch groups have made considerable progress during the previous funding period to develop structural, biochemical, molecular and morphological insights into CFTR structure and dynamics as well as the proteostasis biology that impacts both wild-type (WT) and ΔF508 folding and function. We now hypothesize that the Phe508 deletion is a networking problem at two levels: (1) loss of the energetically stabilizing Phe 508 triggers the loss of key structure-based network interactions within the molecule required to maintain the appropriate balance of dynamics and stability; (2) changes in folding network management by proteostasis biology leading to degradation. We now need to understand these network-based pathways in depth. We further hypothesize that the fold itself and the proteostasis biology managing the fold can be modified to 'repair' ΔF508 function. This renewal application will systematically study the impact of the structure and proteostasis biology based networks on WT and ΔF508 folding to understand why it fails in ΔF508 disease. We propose two Aims to address these central issues in CF. In Aim 1, the Balch lab hypothesizes that understanding the proteostasis biology of WT and ΔF508 CFTR folding is an important key to understanding the defect and that this biology is fully accessible for use in its correction. In Aim 2, the Riordan laboratory hypothesizes that application of computational, biochemical and physiological measures of channel activity and stability for understanding the network of internal structural interactions dictating the WT and ΔF508 CFTR folds will provide critical insight into the organization of the fold and the mechanisms by which it can be stabilized by small molecules in ΔF508 disease. Integration of the Riordan and Balch efforts will lead to a new understanding of how structure and proteostasis biology work together to achieve biological function. A pathway/network-based approach provides a new opportunity to understand the variables confounding ΔF508 function in disease and identify the key nodes in the networks amendable to retune function to improve human healthspan. We hypothesize the general concept that therapeutic management of the emergent properties of folding and proteostasis biology can be used to control the energetics of the CFTR folding landscape and that this new understanding will have a major benefit in the clinic.

Public health relevance
Misfolding diseases such as Cystic Fibrosis are a consequence of the failure of protein folding. We will characterize both the structural and proteostasis biology networks required for folding, and function of WT and ΔF508 CFTR to restore activity in human disease.